NTP Computer and User Support

The NIEHS carries out a variety of studies that require computational support and data analysis, data management, and capture of laboratory data. The objective of this delivery order is to provide the required computational and data management support for a variety of NIEHS research activities.